Treatment of Familial Hypercholesterolemia by Dextran Sulfate Apheresis

Patients with familial hypercholesterolemia (FH) type IIa are at high risk of premature coronary artery disease due to elevated low density lipoprotein (LDL) and Lp(a) cholesterol levels. Diet and drug therapy can reduce cholesterol concentrations in most patients with heterozygous FH, but a small proportion of heterozygotes and nearly all homozygotes do \not respond to therapy. Selective removal of LDL by dextran sulfate affinity adsorption was evaluated in these patients in a collaborative multicenter U.S. study. The dextran sulfate apheresis system (Liposorber LA-15, Kaneka, Japan) removed LDL and Lp(a) without lowering high density lipoprotein (HDL) or albumin levels, thus avoiding the need for colloid replacement solutions. Six FH patients were enrolled at the Clinical Center; the total cohort enrolled nation-wide included 10 homozygotes and 54 heterozygotes. Treatments were administered at 7- to 14-day intervals. Mean acute reductions in total, LDL, and Lp(a) cholesterol levels were 70 percent, 81 percent, and 68 percent, respectively, in homozygotes and 61 percent, 76 percent, and 65 percent respectively, in heterozygotes. Time-averaged levels of LDL cholesterol were reduced 53 percent (447 to 310 mg/dl) in homozygous FH patients and 41 percent (243 to 143 mg/dL) in heterozygous ones. The treatments were very well tolerated. The results of the multicenter study suggest that dextran sulfate adsorption is a safe and effective way to clear plasma of LDL cholesterol, and has advantages, compared to simple plasma exchange, of eliminating the need for colloid replacement solutions and increasing HDL levels.The data gathered in this study were used as the basis for licensure of the LA-15 system, which was approved by the Food and Drug Administration for treatment of FH in July 1996. Patients are now continuing long-term follow-up on an OLDL-Apheresis RegistryO to gather post-licensure data on the effect of long term treatment on development of primary and secondary atherosclerotic events, and on overall survival. A 5-year interim analysis of 49 of the original 64 patients who received long-term LDL-apheresis was performed. There was a 44 percent reduction in cardiovascular events during the 5 years the patients received LDL-apheresis compared with the 5-year period prior to LDL apheresis (3.5 events per 1,000 patient-months of treatment compared with 6.3 events per 1,000 patient-months before LDL-apheresis therapy). These findings support the long-term safety and clinical efficacy of LDL apheresis in patients with FH who are inadequately controlled with drug therapy.